INFORMATION TECHNOLOGY AND INFORMATICS SUPPORT TO THE DIVISION OF CANCER PREVENTION.

This requirement provides information Technology and Informatics support for Division of Cancer Prevention (DCP) (e.g., database administration, data reporting, SharePoint administration, and other informatics programming)